Mitochondrial-Encoded Immunity in Aging

ABSTRACT
Aging is associated with a loss of immune function (immunosenescence) and chronic low-grade inflammation
(inflammaging). However, the mechanistic details of our aging immunity are largely enigmatic. Metabolism and
immunity have co-evolved, and metabolic pathways are increasingly appreciated as key regulators of our immune
system. Mitochondria, being the most important metabolic organelle, have also gained much attention as regulatory
hubs of various immune functions. Owing to their bacterial ancestry, mitochondria possess their own genome.
While mtDNA itself can trigger immune responses and directly entrap pathogens, it is not known to encode for
immune factors. Currently, our immunity is known to be nuclear-encoded. We have recently identified a novel gene
encoded within the mitochondrial DNA and named it MOTS-c (Mitochondrial ORF within the Twelve S rRNA).
MOTS-c is an age-dependent peptide that regulates metabolic homeostasis and significantly improves aging
metabolism and physical fitness in mice.
Here, we describe MOTS-c as the first-in-class mitochondrial-encoded immune factor that acts as an antimicrobial
peptide (AMP). MOTS-c, consistent with other AMPs, is expressed by various cells including monocytes and
macrophages. The identification of MOTS-c was strongly influenced by prior work from the laboratory of Sidney
Pestka (aka “father of interferon”), whereby the great majority of mRNAs induced by interferon were from the
mitochondrial 12S rRNA in monocyte-like cells (no genes were identified at that time). Indeed, we now demonstrate
that MOTS-c peptide expression is induced by interferon gamma. AMPs also regulate immune cell functions,
including monocytes/macrophages. This is consistent with our preliminary data whereby MOTS-c moves to the
nucleus to program monocyte differentiation to generate unique macrophages that are characterized by increased
expression of interferon-stimulated genes (ISGs) and antigen presentation genes. Such “MOTS-c-programmed”
macrophages had increased bactericidal capacity. This observation builds on our recent report on MOTS-c as the
first-in-class mitochondrial-encoded factor that translocates to the nucleus and directly regulates stress-adaptive
nuclear gene expression.
Here, we propose to test the hypothesis that MOTS-c is an age-dependent and IFN-inducible mitochondrial-
encoded AMP, a first-in-class, that programs monocytes to differentiate into unique IFN-poised macrophages with
enhanced bactericidal capacity. We propose three aims to test this hypothesis: (1) Determine whether MOTS-c-
programmed macrophages are epigenetically “IFN-poised” for enhanced antibacterial responses, (2) Test whether
metabolic rewiring enhances bactericidal capacity of MOTS-c-programmed macrophages, and (3) Determine the
functional effect of MOTS-c on monocytes and BMDMs during aging in mice. If successful, we predict that our study
will have broad and lasting impact including (i) the first identification of a mitochondrial-encoded AMP and (ii) the
identification of novel mitochondrial-centric drug class that can restore macrophage function during aging; the
mitochondrial genome has yet to be mined for FDA-approved therapeutics.

Public health relevance
PROJECT NARRATIVE Aging is associated with the decline of immunity at multiple levels that can underlie increases susceptibility to infection and maladaptation to inflammatory conditions. We have identified a first-in-class immune peptide encoded in the mitochondrial genome, that regulates immune cells, in part, by directly regulating the nuclear genome. We propose to investigate the immunomodulatory mechanisms of this mitochondrial-encoded immune peptide and its effect on aging immunity and healthy lifespan.